Epigenome-based Cell Census and Regulatory Element Discovery in the Aging Mouse Brain

PROJECT SUMMARY
Brain cells exhibit profound molecular and cellular changes during aging. Epigenomic marks such as
DNA methylation are associated with age in multiple human tissues, suggesting an alteration of transcriptional
regulation during aging. However, age-­associated epigenomic signatures have not been determined with cell-­
type specificity in the brain. Single-­cell epigenomic strategies, such as single-­cell DNA methylation and open
chromatin profiling assays, are powerful strategies for de novo identification of cell-­type specific epigenome
landscapes in heterogeneous tissues. At the same time, these strategies uniquely allow the identification of cell-­
type specific regulatory elements that control gene expression patterns in complex tissues. The proposed project
will complement and build upon current NIH-­supported BRAIN Initiative efforts to produce an epigenomic cell
atlas of the aging mouse brain at the single-­cell level. Single-­cell DNA methylome and chromatin accessibility
data will be generated to allow identification of cell types and cell-­type specific regulatory elements in the brains
of middle-­aged (9 month old) and aged (18 month old) mice, and in brains of aged mice subject to caloric
restriction. Aging-­associated epigenomic signatures will be identified through comparison to single-­cell
epigenomic data generated from young mice generated by a BICCN U19 Center for Epigenomics of the Mouse
Brain Atlas (CEMBA). Through generation of a comprehensive epigenome-­based brain cell reference atlas of
the aging mouse brain, the proposed research will provide invaluable resources for the aging-­research field.

Public health relevance
PROJECT NARRATIVE In response to RFA- AG- 19- 027 A Census of Cells and Circuits in the Aging Brain, the goal of this project is to understand the cell- type specific alterations in gene regulation during aging, using single- cell epigenomic profiling. Determining such molecular changes in the aging brain will aid in the understanding of gene regulatory mechanisms involved in aging- related cognitive decline and neurodegenerative diseases such as Alzheimer’s.